RADX TECH PROJECT - WORK PACKAGE 1 SUPPORT

We propose to detect acute SARS-CoV-2 infections using a sample-to-answer portable device detecting very low concentrations of viral antigens using our patented microbubbling digital assay technology.